Transformation of a human iPSC-derived bone marrow organoid for the study of hematopoiesis

This proposal is for the transformation of a human-induced pluripotent stem cell (iPSC)-derived bone marrow
organoid for the study of hematopoiesis. The scientific premise of this project is to help overcome the
limitations of current hematopoiesis research models, such as two-dimensional cell cultures and animal
models, by utilizing a human bone marrow organoid. Indeed, organoids have the potential to mimic the
microenvironment and functions of tissues or organs more accurately, bridging the gap between in vitro and in
vivo systems. We have created a bone marrow organoid using iPSCs that replicates key marrow elements like
sinusoidal vessels, stroma, megakaryocyte/endothelial interactions, and myeloid cells. This organoid has
already shown promise in studying hematologic cancers and therapeutic interventions. However, the potential
of the bone marrow organoid extends beyond malignant samples.
In the proposed project, we aim to revolutionize the organoid for the study of hematopoiesis in three specific
aims. The first aim is to perform cellular mapping of the bone marrow organoid over its development using
advanced flow cytometry and microscopy techniques. This will provide valuable information about the changes
that occur in the organoid over time and serve as a resource for the wider hematopoiesis field. The second aim
is to optimize the bone marrow organoid for the study of hematopoietic development. The current protocol,
which focuses on the differentiation of hematopoietic stem and progenitor cells (HSPCs), leads to a
progressive loss of HSPCs over time. By incorporating knowledge from animal models and cell culture
systems, we will develop an iPSC differentiation protocol that maintains a stable HSPC population over a 60-
day period. This optimization is crucial for the organoid model to effectively study hematopoiesis. The third aim
is to culture the organoid under flow using a microfluidics platform. The lack of interstitial flow in the current
model limits its ability to replicate physiological conditions. By culturing the organoid in a 3-channel microfluidic
bioreactor, we will introduce interstitial flow and enhance vascular maturation and maintenance. This setup will
also allow the efficient delivery of small molecules, proteins, and cells into the organoid, mimicking in vivo
blood flow. Further, it will present opportunities for testing therapeutic strategies and studying physiological
mechanisms relevant to hematopoietic diseases. In sum, this project aligns with the goals of the Catalytic Tool
and Technology Development FOA and aims to transform the bone marrow organoid into a novel biological tool
that advances translational hematopoiesis research.

Public health relevance
This application aims to transform a human induced pluripotent stem cell-derived bone marrow organoid for the study of hematopoiesis. The proposed aims will optimize the organoid for the hematopoiesis community by mapping the cellular populations, optimizing the organoid protocol for hematopoietic stem cell maintenance, and culturing the organoid under interstitial flow. The outcome of this proposal has the potential to revolutionize hematopoiesis research by providing a more accurate and physiologically relevant model system, thereby leading to significant advancements in understanding human hematopoietic development and ultimately facilitating the development of new therapeutic interventions.